PSMA ligand radiosensitizers to improve the therapeutic index of external beam radiotherapy for prostate cancer

PROJECT SUMMARY/ABSTRACT:
Radiation therapy has a definitive role in curing high risk, very high risk, and even oligometastatic or low-
volume metastatic disease as phase III trials in these settings have demonstrated overall survival benefits.
However, radiation therapy also involves incidental radiation dose to rectum, small bowel and urethra, which
cause radiation dose-limiting toxicity. Locoregional control, particularly within pelvic lymph node regions where
currently possible radiation doses are non-curative, can be a limiting factor in overall prostate curability in these
settings. In this proposal, we seek to create state-of-the-art PSMA-targeting therapeutics, taking advantage of
this relatively prostate-specific surface antigen. We will create two molecules consisting of the PSMA ligand
linked to a lysosomal cleavable linker which is turn linked to radiation sensitizing small molecule inhibitors of
the DNA damaging response. One molecule will involve a potent inhibitor of ATM and the second will involve
an inhibitor of DNA-PK, two targets integral to radiation efficacy. In SA1 we will test these novel molecules with
in vitro assessments of inhibition of the ATM and DNA-PK kinases in PSMA expressing prostate cancer cell
lines compared to PSMA non-expressing cells. In SA2, we will test these molecules for in vivo efficacy in
prostate cancer xenografts and determine target engagement and preliminary normal tissue toxicity. The
overarching goal addressed by the proposed research project is to develop treatments that could improve
survival for men with lethal prostate cancer by improving locoregional control, which does impact overall
survival in these men. In addition, if these molecules successfully radiosensitize, it is also possible they will
allow for external beam radiation dose de-escalation and enable less normal tissue toxicity in order to improve
quality of life outcomes. Finally, in downstream work the molecules could be combined with Radium-223 to
systemically radiosensitize a therapy proven to extend survival. In this pilot grant, we will determine the initial
feasibility of this approach, laying the groundwork for further therapeutic development.

Public health relevance
PROJECT NARRATIVE: Radiation therapy is commonly used to cure prostate cancers, including cancers confined to the prostate gland itself as well as prostate cancer that has spread to surrounding lymph nodes or other tissues. However, many patients are not cured of prostate cancer after radiotherapy due to restrictions in dose required by the limited radiation tolerance of adjacent normal tissues. In this proposal, we will attempt to develop a novel therapeutic drug that could improve outcomes for these patients by sensitizing only prostate cancer cells to the effects of radiotherapy and spare other tissues, such as bowel.